Development of flavone- and flavonoid-based DNA triplex specific binding ligands as antigene enhancers

Project Summary
The proposed research objective is to acquire an advanced gel imaging system to enhance the
ongoing research on studying the structure-function relationship between triplex DNA and a class of
newly discovered flavonoid-based triplex-specific binding ligands. Knowledge of ligand-mediated
triplex formation can be used to design potent antigene enhancers in the antigene strategy for disease
treatment. This gel imaging system will be used in three sets of experiments. 1) A plasmid DNA
containing four restriction endonuclease DraI cleavage sites will be constructed. One of the DraI
cleavage sites resides in a triplex-forming region. The ligand-mediated triplex formation will protect
this cleavage site from DraI digestion. The cleaved DNA fragments can be separated by agarose gel
electrophoresis and observed on the new gel imaging system via fluorescence. Based on the DNA
fragments obtained from DraI digestion, we can determine the efficiency of ligand-mediated triplex
formation on inhibition of enzymatic activities. High-quality gel images will be obtained. 2) Fluorescent
probe labeled triplex-forming DNA oligonucleotides will be synthesized. The purine strand of duplex
DNA is labeled with a green probe, and the triplex-forming oligonucleotide is labeled with a red probe.
The formed DNA will be separated using polyacrylamide gel electrophoresis. The ligand-mediated
triplex formation will result in different color schemes representing the formation of duplex and triplex
DNA (duplex DNA: a green band; triplex DNA: a yellow band; no duplex or triplex DNA formation:
separated red and green bands). This color scheme can be readily observed using multiplex detection
on the new gel imaging system. 3) A plasmid DNA containing a red fluorescent protein (mcherry) will
be constructed. The upstream of the mcherry sequence contains a triplex-forming site. The ligand-
mediated triplex formation will reduce the synthesis of red fluorescent protein in live cells (E. coli). The
fluorescence in live cells (in vivo) can be visualized using the plated-based imaging on the new gel
imaging system. The acquisition of an advanced gel imaging system allows us to conduct high-quality
gel imaging experiments proposed in the parent award with 24/7 access and to expand our research
capability to perform multiplex imaging and in vivo imaging. In addition, it introduces state-of-the-art
imaging technology to our undergraduate and graduate students to enhance their experiential learning
experience at Pacific and improve the research infrastructure at our undergraduate-centered
institution.

Public health relevance
Project Narrative The proposed research is intended to purchase an advanced gel imager system to study ligand-mediated triplex formation and its inhibition of enzymatic activities. The long-term goal is to use the obtained knowledge to design and develop more potent triplex-specific binding ligands as enhancers to facilitate the formation of triplex DNA to regulate pathogenic activities.